Assessing an Initiative to Facilitate Long-Term Financial and Housing Stability in Vulnerable Veterans

Background and Significance: Through the Shallow Subsidy component of the Supportive Services for
Veteran Families (SSVF) program, Veterans and their families living in high cost-of-living locations in the US
who are experiencing homelessness or at risk of becoming homeless can receive up to 2 years of rental
subsidies and job training through non-profit organizations in the community. The goal of the program is for
Veterans to achieve long-term financial self-sufficiency through employment and housing stability. The impact
on Veteran housing, healthcare cost, and health outcomes as well as Veteran satisfaction with this program is
not known.
Poverty has a devastating effect on Veterans’ health and well-being. In addition, homelessness can be
costly both to the healthcare system and society as a whole. Solving the problem of long-term Veteran financial
and housing instability is one of the most important initiatives the VA is currently pursuing.
Innovation: Our study – evaluating a program implemented in 15 different communities in the US – will be the
largest to examine the impact of long-term financial support for individuals facing housing instability in the US.
In addition, we will use both structured and unstructured data and detailed, Veteran-level data on services and
financial assistance received by Veterans enrolled in this program. Finally, we will join VA clinical data with tax
filings data available through the US Department of the Treasury to estimate the impact of Shallow Subsidies
on income and employment outcomes.
Specific aims: Aim 1: Identify barriers and facilitators to implementation and use of the Shallow Subsidy
program using semi-structured interviews with VA operations partners, SSVF grantee employees, VA
homeless services providers, and Veterans using the Shallow Subsidy program. Aim 2: Describe and identify
predictors of the amount of financial support for Veterans enrolled in the Shallow Subsidy program for FY2020-
FY2023 using HMIS, VA administrative, and publically-available community-level data. Aim 3: Perform an
outcome and economic assessment of the Shallow Subsidy program. 3a: Measure the impact of this program
on housing, income, employment, health, and healthcare cost outcomes through retrospective cohort analyses
for FY2020-FY2023. 3b: Conduct economic evaluations of the Shallow Subsidy program compared to standard
SSVF and usual care using input parameters from the published literature and from Aims 2 and 3a.
Methodology: In Aim 1, we will conduct interviews with national VA stakeholders, SSVF grantee employees,
VA homeless service providers, and Veterans who have enrolled in the SSVF program. In Aim 2 we will
construct multi-level regression models to identify both individual- and community-level predictors of Shallow
Subsidy use and expenditures. In Aim 3a, we will fit outcome models relating Shallow Subsidy program
initiation to the subsequent mortality, exit from homelessness, income, employment, and cost outcomes in
weighted populations defined by propensity scores. In Aim 3b, we will construct simulation models using input
parameters from a variety of sources.
Next steps/Implementation: This research will be an important building block for future studies. We will work
with our operations partners to design studies to implement and assess the policy recommendations from this
study to enhance the Shallow Subsidy program. This information will be especially important as the SSVF
program office is considering expanding the Shallow Subsidy program to other communities throughout the
country. In addition, in future analyses we will examine the impact of health conditions (such as traumatic brain
injury, combat injury, and opioid misuse) and interventions to address these conditions on income and
employment. Through this portfolio of research projects, we will help VA efficiently deliver services to improve
the lives of vulnerable Veterans.

Public health relevance
Poverty has a devastating effect on Veterans’ health and well-being. Through the Shallow Subsidy program, Veterans and their families living in 15 high-cost communities throughout the country who are experiencing housing instability can receive long-term rental assistance and job training with the long-term financial self- sufficiency. The impact of the Shallow Subsidy program on Veteran housing, healthcare cost, health, income, and employment outcomes as well as Veteran experience with this new program is not known. Through this project, we will generate important information about the Shallow Subsidy program. We will use nationwide data to describe the geographic variation in Shallow Subsidy services and expenditures throughout the different, eligible communities. We will measure the impact of Shallow Subsidy on Veteran outcomes as well as the cost-effectiveness of the program relative to usual care. Finally, we will interview Shallow Subsidy participants to better understand barriers and facilitators of the program.